Analyzer-based Phase-Contrast Orthopedic Imaging

The proposed project concerns with evaluation of an analyzer-based phase contrast imaging (ABI), for orthopedic imaging. ABI is a modality that uses x-ray refraction to produce dramatic improvements in imaging of the soft tissues. ABI has been well documented to produce extraordinary images at synchrotron facilities. We have developed a breakthrough approach, now included into our full scale prototype that can deliver images under 10sec. This prototype is design for breast imaging. The goal of the proposed project supplement will be to evaluate its output in an expert reader study for orthopedic imaging application and also assess if the system cost can be reduced. ABI imaging offers many important potential benefits: 1) ABI has very high inherent soft- tissue image contrast due to the physics of x-ray refraction and strong scatter rejection, promising to provide clear visualization of bonnie structure as well as soft tissue which includes muscles, ligament and tendons; 2) currently ABI is a planar-imaging method like radiography, but can also be used in computed tomography (CT) modes; 3) ABI has no need for injected contrast agent; 4) ABI has potential to reduce radiation dose; 5) the image detail seen in ABI may ultimately eliminate the need follow CT or MRI imaging. The main elements in this supplement will define the project's specific aims as follows: 1. Evaluate existing imaging system using ex vivo foot and thumb specimens using expert orthopedic surgeons and radiologist. 2) Optimize system cost by evaluating if a smaller (therefore cheaper) detector and crystals can be used without performance reduction.

Public health relevance
The development of clinically practical analyzer-based phase-contrast imaging system for orthopedic imaging may have major significance for 124Milion of Americans suffering from musculo-skeletal disorder or joint pain. This system produces high-contrast soft- tissue images that allow clearer visualization of the joint's soft-tissue. This will result in fewer unnecessary follow-up tests aiding faster and better treatment as well as surgical planning.